ROUTINE WEEKLY SPECTROMETER MAINTENANCE AND LIQUID NITROGEN FILLS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This narrative covers the time dedicated to liquid nitrogen fills and routine maintenance of the spectrometers. This is conducted on a weekly basis.